MHC class II immunopeptidomics analysis of the SARS-CoV-2 proteome

SUMMARY OF RESEARCH PROJECT
COVID-19 is a global pandemic, the scope of which has not been seen in a century, and there is a critical unmet
need for a vaccine to provide herd immunity against SARS-CoV-2. The objective of this proposal is to identify
conserved immunodominant MHC class II peptides from the SARS-CoV-2 proteome that may be incorporated
into current vaccine design studies. This meets a critical need to design a vaccine that will provide long-term
protective immunity against COVID-19.
This proposal uses an innovative immunopeptidomics platform to define the human SARS-CoV-2 MHC class II
immunopeptidome using tandem mass spectrometry (Aim 1), and to determine CD4+ T cell responses to
potentially immunogenic SARS-CoV-2 MHC-II peptides using a humanized mouse model (Aim 2). Robust CD4+
T cell responses to viral peptides are essential for establishing a pool of long-lived memory B cells and cytotoxic
T cells. Results from this study will provide valuable insights into CD4+ T cell responses to viral proteins that
may be rapidly incorporated into a vaccine design that will provide long-lasting protection from COVID-19.

Public health relevance
PROJECT NARRATIVE COVID-19 is the most severe pandemic in a century, and development of a safe and effective vaccine is critically needed. Activation of virus-specific CD4+ helper T cells is needed for establishing a pool of long-lived memory B and T cells. This study will identify MHC class II antigens derived from the SARS-CoV-2 proteome that are important in eliciting CD4+ T cell responses to viral proteins which can be incorporated into a vaccine design.